Formulation, processing and performance interrelationships for amorphous solid dispersions

Project Summary It is estimated that up to 90% of emerging drug candidates have significantly less than optimal aqueous solubility, which will impede their efficient delivery to the body. Amorphous solid dispersions (ASDs) have emerged as an important approach to improve oral bioavailability of low solubility drugs. However, the interplay of manufacturing conditions, polymer choice, and storage conditions on the critical quality attributes of ASDs that impact dissolution, precipitation and ultimately in vivo performance is poorly understood. There is also concern within the medical community that generic ASD products may not perform as well as brand products. The objective of the current proposal is to evaluate the impact of formulation components, processing parameters and storage conditions on the in vitro and in vivo performance of ASDs of relevant poorly water soluble drugs. The rationale for this research is that its successful completion will enable an understanding of processing and formulation factors that impact the robustness of brand and generic ASD formulations, insuring product quality. The specific aims are to: 1) Demonstrate that drug–polymer miscibility depends both on drug and polymer chemistry and on processing conditions, comparing ASDs prepared with spray drying and melt extrusion. 2) Using innovative analytical approaches, show that differences in product performance for ASDs prepared with spray drying versus hot melt extrusion depend on critical quality attributes that include, drug–polymer homogeneity, residual crystallinity and dissolution performance. Determine critical process parameters specific to each manufacturing technique that impact these critical quality attributes. Demonstrate that precipitation behavior can be modified by formulation components and that precipitation to a non?crystalline form has very different consequences for product performance compared to crystallization. 3) Compare and contrast the quality attributes of brand and generic ASD products in terms of assay, related substances, dissolution performance and other critical quality attributes. 4) Compare and contrast brand and generic ASD formulations in terms of the robustness of the formulation to stressed storage conditions. Performance attributes that will be assessed include evolution of crystallinity with time as a function of moisture content, as well as dissolution rate and precipitation tendency/outcome at different time points. 5) Conduct a clinical trial to evaluate the in vivo performance of fresh and aged brand and generic ASD preparations.

Public health relevance
Project Narrative Sophisticated formulations are needed for drugs which are not very water soluble in order to deliver them to the body following oral ingestion. This research will explore critical factors that impact the effectiveness of these formulations. This will help insure that brand and generic products of poorly water soluble drugs are safe and efficacious throughout their shelf‐life.